Advanced Quantitative Magnetic Resonance Imaging Phantoms for Nonalcoholic Fatty Liver Disease

PROJECT SUMMARY
The overall goal of this Phase I proposal is to design and test the feasibility of novel magnetic resonance
imaging (MRI) reference standards (“phantoms”) that are urgently needed for comprehensive and standardized
quality assurance (QA) of quantitative MRI biomarkers of non-alcoholic fatty liver disease (NAFLD). We propose
to develop 1) a quantitative MR elastography (MRE) stiffness phantom, and 2) a combined quantitative MRE
and proton density fat fraction (PDFF) phantom that mimics the simultaneous presence of liver fibrosis and fat.
Over the past decade, quantitative MRI methods, including MRE to measure stiffness as a biomarker of liver
fibrosis and chemical shift encoded MRI (CSE-MRI) to measure PDFF as a biomarker of liver fat, have emerged
as the noninvasive standard of care for assessment of NAFLD. The rapid adoption of MRE and PDFF methods
at thousands of sites worldwide has created an urgent need for quantitative MRE and PDFF phantoms that
enable robust quantitative QA to ensure unbiased and reproducible measurements. Lack of clinical QA can
result in misdiagnosis, and inadequate QA in clinical trials can result in errors and inconsistency in the primary
trial endpoints (liver stiffness and PDFF) leading to loss of valuable patient data and potentially a failed trial.
Currently available single-stiffness MRE phantoms are insufficient for quantitative QA because they mimic only
a single stiffness value which drifts over time. These phantoms also require phantom-specific MRE protocols
that differ significantly from clinical MRE protocols, leading to technical failures and a cumbersome QA process.
Importantly, most clinical MRI protocols evaluating NAFLD measure both MRE-stiffness and PDFF in the
same exam. Through market research, Calimetrix has identified the need for two new quantitative phantoms: 1)
a multi-stiffness MRE phantom; and 2) a combined MRE/PDFF phantom. Both phantoms must be stable over
time and be designed to simplify QA setup, minimizing user and technical errors.
In this proposal, we have assembled a team consisting of the primary inventors of both PDFF and MRE
including experts from the University of Wisconsin, Calimetrix, the Mayo Clinic, and Resoundant. We propose to
design, develop, and validate chemical formulations for gels of varying stiffnesses that span the clinically relevant
range of liver stiffness (Aim 1) and emulsions with simultaneously varying stiffness and PDFF values that span
the clinically relevant range of liver stiffness and fat (Aim 2). We also propose to design and validate a phantom
housing that facilitates accurate quantitative measurements and is efficient and easy-to-use with separate
compartments to contain multiple stiffness and/or PDFF values in a single compact unit (Aim 3), and finally, to
demonstrate the feasibility of the MRE and MRE/PDFF phantom prototypes, including ease-of-use, high image
quality, and utility for QA of clinical MRE and CSE-MRI protocols (Aim 4). If successful, we will have developed
and demonstrated the feasibility of truly quantitative MRE and MRE/PDFF phantoms that are urgently needed
for quality assurance of quantitative MRI biomarkers of NAFLD.

Public health relevance
PROJECT NARRATIVE: The broad, long-term objective of our research is to improve the health of nearly 100 million Americans who suffer from nonalcoholic fatty liver disease (NAFLD). New commercially available quantitative magnetic resonance imaging (MRI) methods can non-invasively detect and measure important features of NAFLD. Highly controlled and reliable test objects, or “phantoms”, that accurately mimic the disease features of NAFLD are needed to perform quality assurance of these quantitative MRI methods - this proposal aims to develop, validate, and demonstrate the feasibility of two novel quantitative MRI phantoms.